Adversity, Aging and ADRD Risk among the Global Poor: A Biosocial Lifecourse Approach

Project Summary/Abstract:
Accelerated aging, or the earlier onset and faster pace of cognitive decline along with broader declines in physical
and mental health, is a distinctive yet poorly understood hallmark of aging in low-income countries (LICs) where
individuals are often exposed to multiple recurrent adversities. Research that integrates biological and social
data promises key insights into the biosocial lifecourse dynamics that shape the aging process and contribute
to accelerated aging and Alzheimer’s Disease and Related Dementia (ADRD). However, the vast majority of
biosocial research on aging and ADRD has been conducted in high-income countries (HICs), with only 16% of
the world’s population, compared to low-and middle-income countries, which have 84% of the global population
and exhibit higher current and future projected cases of dementia. This project will help fill this gap by collecting
genomic and epigenomic data on adults aged 45 plus in the Malawi Longitudinal Study of Families and Health
(MLSFH) (N=3,500). Over 25 years of existing lifecourse social, contextual, and health data in MLSFH will be
supplemented with epigenetic aging biomarkers and additional longitudinal measures of cognition to study the
risk and resilience factors that shape the evolution of accelerated aging and cognitive decline in an LIC context.
The resulting longitudinal biosocial MLSFH aging data will be unique within LICs and will allow us to pursue
two aims that are at the forefront of current aging research: Aim 1–Lifecourse adversities and epigenetic aging
biomarkers: Investigate critical factors contributing to accelerated aging in an LIC population with extensive
lifecourse adversities by (a) evaluating existing and novel epigenetic biomarkers of aging, and (b) testing their
relationship to lifecourse adversities, health behaviors, and underlying genetic predisposition. Aim 2–Epigenetic
aging biomarkers and ADRD risk among older adults in an LIC: Investigate the relationship between epigenetic
biomarkers and cognitive function/decline and ADRD to evaluate the biosocial determinants of ADRD in a
LIC population experiencing high levels of adversities. The overall hypothesis guiding this project is that new
epigenetic aging biomarkers derived from the MLSFH data will illuminate distinct biosocial pathways of aging
that are unique to LIC contexts, and that the cumulative and synergistic effects of lifecourse adversities and
genetic predispositions will influence the initiation and progression of accelerated epigenetic aging and cognitive
decline. The overarching innovation of this project is the implementation of a biosocial research agenda in a rarely
investigated population in aging research: a large-scale LIC cohort in sub-Saharan Africa. Results will enhance
our understanding of the biosocial determinants of aging and cognitive decline and illuminate potential areas for
healthy-aging interventions in LIC settings where the lack of effective health-system responses has been a barrier
to enhancing the health and quality of life in older adults. By making data publicly available, an important project
goal is also to generate a novel public resource that significantly enhances the diversity of study populations for
global biosocial aging and ADRD research.

Public health relevance
Narrative/Public Health Relevance: This project is relevant to public health because it will evaluate the joint effects of social and biological forces on accelerated aging and Alzheimer’s Disease and Related Dementias (ADRD) in low-income countries and will provide evidence to inform policy interventions aimed at reducing global dispar- ities in life expectancies and quality of life among older adults. The project will supplement a quarter-century of social and contextual data in the Malawi Longitudinal Study of Families and Health with additional longitudi- nal measures of cognition and genomic and epigenomic data (N=3,500) to characterize the impact of lifecourse adversities on disparities in epigenetic age acceleration and cognitive decline. Results from this project will con- tribute to attenuating the extreme Eurocentric bias in publicly available genomic and epigenomic data and will enhance our understanding of how social and environmental exposures interact with behaviors and biology to shape accelerated aging and ADRD in low-income countries.